Regional Medical Library for Region 3 of the Network of the National Library of Medicine: Admin

The Gibson D. Lewis Health Science Library of the University of North Texas Health Science Center at Fort Worth proposes to host the Regional Medical Library for Region 3 of the Network of the National Library of Medicine (NNLM) in order to support its mission of working through libraries and other network members to support a highly trained workforce for biomedical and health information resources and data, improve health literacy, and promote access to health information for all. Region 3 will serve as a regional hub to develop a highly skilled workforce, ensure proper stewardship of funds, and develop unique engagement opportunities for network member libraries and other organizations to carry out regional and national programs. The Specific Aims of the Administrative Core, with numbering continued from the Overall Specific Aims, will be to (3) foster an open, data-driven culture that takes a systematic approach to implementing external outreach activities and organizational processes in cooperation with other RMLs, NNLM Offices and Centers, the NNLM Evaluation Center (NEC), and NLM's Office of Engagement and Training (OET); (4) create integrated, multi-level engagement strategies for sustaining and growing network membership; (5) and collaborate within the region as well as with other RMLs, NNLM Offices and Centers, and the NNLM Evaluation Center (NEC) to prepare for and ensure continuity of service in the event of a disaster. A culture of transparency and assessment will be accomplished by drawing on agile project management principles. By taking a more iterative approach to planning and tracking progress, Region 3 will be able to respond more rapidly to changes in the health information environment. Network membership strategies will be based in marketing and branding practices from the business world, utilizing multiple channels of bidirectional and one-way communication that appeals to a variety of audiences in the region. For disaster preparedness and response, Region 3 will partner with Region 1 to aid with continuity of business operations should an all- hazards event result in the closure of one of the RMLs.